IGF::OT::IGF Base Award. Creation of an Accurate Model of the Topical Structure of PubMed and Associated Indicators. POP: 09/01/17 - 02/28/18. N43DA-17-1215.

The Contractor will develop advanced and sophisticated analytical models, tools and metrics to enhance the professional evaluation and decision making in life sciences management and administration. The intended result is a novel set of metrics that can be used by NGOs/disease foundations, advocacy groups, research funders, policy makers and by academic institutional bodies.